Development and validation of cardiovascular MRI techniques on a low-field, ultra-wide bore system to assess patients with severe obesity

Project Summary/Abstract
Obesity has reached epidemic proportions in the USA, with more than 40% of the population classified as obese
(body mass index (BMI) > 30 kg/m2), and nearly 10% as severely obese (BMI > 40 kg/m2). Cardiovascular
disease (CVD), especially heart failure, is highly associated with obesity. Reliable non-invasive cardiovascular
imaging tests are needed to provide accurate diagnosis and prognosis in this patient group. Unfortunately, obese
patients present a diagnostic challenge to current non-invasive cardiovascular imaging modalities. Computed
tomography and single-photon emission computed tomography can require excessive radiation for successful
imaging of obese patients, while echocardiography suffers from limited windows and signal attenuation leading
to degraded image quality. Magnetic resonance imaging (MRI) of obese patients at conventional field strengths
(1.5T and 3.0T) is primarily limited by narrow patient bore and table weight limits. As lower field strength allows
greater flexibility in magnet design, a new low-field (0.55T) MRI with a unique, ultra-wide 80 cm bore and 700 lb.
table weight limit that can accommodate severely obese patients was recently announced by Siemens. One of
the first such systems in the USA will be installed at our institution this summer. In this project, we will develop
cardiovascular MRI techniques for this system, and demonstrate their clinical value in severely obese patients.
Our group and others have recently shown initial feasibility of cardiovascular imaging at low field. We believe
that this new low-field MRI platform, when combined with the advanced pulse sequences and image
reconstruction methods developed by our team, can unlock the potential of this novel system as a more reliable
means to provide non-invasive cardiovascular imaging to patients with severe obesity. Furthermore, the reduced
field strength will make MRI safer and more effective in the growing number of patients with implanted devices.
We will prove low-field MRI utility for CVD assessment. Aim 1 will establish the feasibility of low-field
cardiovascular MRI regardless of body habitus. We will develop image acquisition and reconstruction techniques
specifically designed to compensate for the reduced MR signal at 0.55T compared to higher field. This will offer
a comprehensive assessment of cardiovascular structure and function, and myocardial tissue. Aim 2 will validate
these techniques in normal weight to severely obese healthy individuals and CVD patients, by head-to-head
comparison with standard 70 cm bore 1.5T MRI in those able to safely fit in both machines. Aim 3 will apply the
validated techniques to evaluate the efficacy of a low-field cardiovascular MRI exam in heart failure patients who
are severely obese (BMI > 40 kg/m2) and cannot be safely imaged on standard MRI systems. We will compare
the comprehensive diagnostic value of 0.55T MRI against echocardiography, and will correlate MRI markers to
clinical symptoms of heart failure severity determined by a six minute walk test in these patients.
The cardiovascular techniques that we develop for this imminent novel 0.55 T MRI system provides a timely
solution for effective clinical care and management of the increasing population of severely obese CVD patients.

Public health relevance
Project Narrative The prevalence of severe obesity continues to rise and is strongly linked to many forms of cardiovascular disease; unfortunately, cardiovascular imaging is challenging in these patients as their large size limits accessibility to some imaging modalities, and leads to poor image quality in others, reducing diagnostic accuracy. The use of cardiac magnetic resonance imaging (MRI) is currently limited by the narrow bore and table weight limits of standard MRI machines operating at 1.5T and 3.0T. In this project, we will develop cardiac MRI techniques for a new, low-field, 0.55T MRI machine with an ultra-wide 80 cm patient bore and 700 lb. table weight limit to provide a robust diagnostic cardiovascular imaging option for severely obese patients.